TSH Receptor Autoregulation

ABSTRACT
The thyroid stimulating hormone receptor (TSHR) is the major control center of the thyroid cell
and the target of autoimmune thyroid disease. The TSHR is a GPCR on the thyroid cell but is
not confined to the thyroid since it has widespread extrathyroidal expression in fibroblasts,
adipocytes, bone cells and brain tanycytes where they are presumably associated with unique
roles. Recently, using Molecular Dynamic (MD) simulation studies we identified water channels
within the TSHR transmembrane domain (TMD). Furthermore, using an in vitro assay of water
transport in thyrocytes, we have shown that receptor activation with TSH ligand, TSHR specific
small molecules and TSHR stimulating antibodies all enhanced water flow. In this proposal we
intend to examine the mechanism of TSHR water transport and its link to receptor signaling,
discover novel small molecules that can modulate this water transport leading to physiological
changes and marry these observations to translational effects on brain hypothalamic tanycytes.
Therefore, the specific aims are:
Aim 1: How is water transported within the TSHR- TMD water channels and does water passage
affect TSHR signaling?
Aim 2: Can we identify novel TSHR specific small molecules that influence water transport?
Aim 3: Does the TSHR water channel influence hypothalamic tanycyte actions?
These studies will determine if modulation of TSHR signaling in the thyroid cell and many other
extra-thyroidal sites is secondary to water channel function and may perturb cellular
homeostasis.

Public health relevance
PROJECT NARRATIVE The thyroid gland provides thyroid hormone to all the tissues of the body. The thyroid may become diseased and develop tumors, become overactive or become underactive; all with profound problems for the patient. Thyroid disease is common in our Veteran population, both men and especially women, and the proposed studies are intended to learn more about the role of the receptor for thyroid stimulating hormone (TSHR) which is found not only in the thyroid but also in many parts of the body including fat and bones and skin, behind the eyes and in the brain. Surprisingly, we have recently found water channels within the TSHR which are regulated by TSH and our proposal is designed to learn about their characteristics and role in normal physiology and whether we can regulate them for a therapeutic advantage..